Pilot Project 1

PILOT PROJECT 1: PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is a highly fatal disease with mortality running parallel to its incidence. Lack of
effective treatment for advanced HCC calls for insights into the molecular pathogenesis of HCC and development
and evaluation of novel, targeted therapeutic strategies. For HCC patients, there is a statistically significant
increase in incidence and mortality and a decrease in 5-year survival rates in African American (AA)/Black
patients compared to non-Hispanic (white) patients. There is a gap of knowledge in our understanding of the
molecular mechanism underlying the HCC racial disparity between AA/Black and white patients. Analysis of
RNA-sequencing (RNA-Seq) data in the TCGA database and RNA-Seq on HCC tumor samples revealed that in
both datasets the only pathway that showed statistically significant activation in AA/Black patients is the type I
interferon (IFN-I) signaling pathway. This pathway is activated by Hepatitis C virus (HCV) infection, a major risk
factor for HCC. Correction of the differential gene expression data based on HCV status still identified activation
of IFN-I signaling pathway in AA/Black HCC patients indicating that the observed findings in AA/Black patients
are independent of HCV status. HCC is a disease of chronic inflammation and IFN-Is function as pro-
inflammatory and immunosuppressive cytokines, establishing the rationale for studying them. We hypothesize
that persistent activation of the IFN-I signaling pathway might be a key determinant of racial disparity in AA/Black
HCC patients, and even if IFN-I-inducible genes (ISGs) are induced in response to HCV infection in AA/Black
patients their expression is maintained—contributing to HCC development and virulence. In this study, the role
of a 4-ISG signature in regulating HCC in white and AA/Black patients will be systematically analyzed using HCC
patient-derived xenograft (PDX) cell lines and the efficacy of dietary anti-inflammatory compounds in inhibiting
them will be evaluated. The proposed studies will help develop a targeted therapeutic approach for AA/Black
HCC patients thus having both mechanistic and therapeutic significance and innovation. Successful completion
of the proposed studies will create new avenues for effective treatment of scores of AA/Black HCC patients for
whom currently no effective treatment option is available.

Public health relevance
PILOT PROJECT 1: PROJECT NARRATIVE For hepatocellular carcinoma (HCC), race/ethnicity plays an important role in determining incidence, mortality and survival rates. The present proposal aims at analyzing the role of pro-inflammatory type I interferon signaling in determining virulence of African American (AA)/Black HCC patients and evaluating the efficacy of dietary anti- inflammatory compounds in inhibiting AA/Black HCC patient-derived xenografts.